Under Pressure: Biophysical Mapping of Herpesvirus Capsid Assembly and Genome Packaging

Project Abstract
Herpesviruses are double-stranded-DNA viruses that infect most of the human population. These complex
viruses establish lifelong, dormant infections, periodically reactivating under certain conditions. Reactivation is
particularly detrimental to the immunocompromised, resulting in a variety of disease states, including blindness,
encephalitis, cancers, and death, yet there is no cure. There are nine types of human herpesviruses, classified
into three subfamilies, yet a vaccine is only available targeting one type. Furthermore, available antivirals are
suboptimal due to viral mutation. The lack of pan-herpesvirus therapeutics likely stems from the variations in
viral replication between subfamilies, yet certain aspects, such as the need for properly assembled capsids
containing genetic content, are conserved. Therefore, the long-term goal of this research is to formulate a
detailed mechanism as to how herpesviral capsids assemble and package DNA, both of which are essential for
all herpesviruses to replicate. Although great strides have been made over the years to understand these
processes, we still do not know how these dynamic and transient processes occur at the molecular level.
Therefore, the scientific premise of this work is to develop biophysical methodologies to monitor capsid
assembly and genome packaging in real-time. The work in this proposal capitalizes on an existing in-vitro capsid
assembly platform that we will use in conjunction with new technologies in light scattering and mass spectrometry
to understand how individual capsid proteins come together to form the capsid shell. Not only will this provide
missing information regarding this essential process but it will also create new methodologies for other
researchers studying large viruses. Additionally, work in this proposal will create a novel in-vitro herpesviral
capsid packaging assay, something that has yet to be done in the field. We will subject this assay to various
single-molecular approaches to understand how proteins involved in genome packaging, some with unknown or
incompletely defined roles, coordinate this process to achieve successful encapsidation. Together, these
innovative studies will not only provide fundamental knowledge regarding these essential processes but also
challenge existing paradigms, resulting in a more complete understanding of herpesviral replication that can be
exploited for preventative and therapeutic approaches.

Public health relevance
Project Narrative Herpesviruses infect most of the human population, establishing incurable, lifelong, dormant infections that upon reactivation, can result in severe disease states and fatalities, particularly among the immunocompromised. The complexity of these viruses, along with divergent aspects of viral replication among the three subfamilies infecting humans, have hindered the identification of pan-herpesviral preventions and treatments. Therefore, the goal of this proposal is to develop a deep understanding of how herpesvirus capsids assemble and package DNA, two essential steps required for all herpesviruses to spread infection, and use this information to develop novel therapeutic interventions.